New Technology for Functional Studies of the Kinome

DESCRIPTION (provided by applicant): There is a need for new technologies to enable the analysis of the protein coding content of a genome. We propose to develop a novel technology for generation and screening of peptide substrates for kinase activity profiling. The technology is designed to enable large scale kinase activity profiling studies. PUBLIC HEALTH RELEVANCE: The kinase substrate screening technology we are developing will help to enable large- scale studies of kinases. This is useful for identifying new drug targets and for drug development. It would help to guide experiments to elucidate the functional roles of specific kinases and may also prove to be a sensitive diagnostic tool, and therefore may result in medical advances in the diagnosis and treatment of disease.

Public health relevance
The kinase substrate screening technology we are developing will help to enable large- scale studies of kinases. This is useful for identifying new drug targets and for drug development. It would help to guide experiments to elucidate the functional roles of specific kinases and may also prove to be a sensitive diagnostic tool, and therefore may result in medical advances in the diagnosis and treatment of disease.